Scientific Information Management and Literature-based Evaluations for the NTP - Support for Systematic Review on PAHs/Nitro PAHs

The Division of NTP performs systematic reviews of literature to assess the potential for adverse effects on human health by agents, substances, mixtures, or exposure scenarios, based on information about human exposure. The findings of these reviews generally focused on either cancer or non-cancer effects and published as monographs. These reviews are conducted primarily by the DNTP Integrative Health Assessment Branch in support of the congressionally mandated Report on Carcinogens (ORoC). The ORoC lists substances that pose a cancer hazard for people living in the United States, and documents related to the cancer hazard evaluation of substances as potential new listings in the report. This systematic review focuses on understanding the carcinogenic potential of exposure to polycyclic aromatic hydocarbons (PAHs) and nitro-PAHs. Keywords: Systematic review, toxicology, epidemiology, exposure, cancer, PAH, nitro PAH